Administrative Core

Administrative Core Summary
Effective administration is critical to the mission of the Program. The major goals of the Administrative Core
are to coordinate and direct Program efforts, to interface with other leaders/efforts in the field, and to interface
with NCI. As part of this effort, the Administrative Core will also organize outside speaker visits, scientific
retreats, and the annual External Advisory Committee (EAC) meetings. The Administrative Core will also
monitor progress in the Program and effective use of the Shared Resource Cores. To achieve these goals, the
Administrative Core will be led by the Program Principal Investigator, Dr. Alissa Weaver. Dr. Weaver will
interface with all Core leaders at formal quarterly meetings, and all Project leaders at monthly meetings to
review progress and determine what, if any, changes need to be made. In addition, every two weeks the entire
Program investigator group will meet for data presentations. At those meetings, Projects and Cores will
alternate presenting scientific results and we will also communicate any Program news or discuss any issues.
Once a year, we will hold an Annual Research Retreat. A Program Administrator will facilitate organization and
communication with Program members and outside investigators, including the EAC. The frequent meetings
and formal structure that we will put in place will facilitate communication, allow early recognition of any
problems that need to be addressed, allow capitalization on any opportunities, and ensure integration of the
group and scientific synergy.

Public health relevance
Administrative Core Narrative The Administrative Core is important to organize the whole Program, which is focused on understanding how RNA secretion alters the tumor microenvironment and drives colon cancer aggressiveness.